TASK A94: Mouse Models for Therapeutics Testing Against Ebola Virus

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.